Fast high-resolution simultaneous metabolic and multiparametric imaging of the whole brain

PROJECT SUMMARY
The ongoing paradigm shift in healthcare towards personalized and precision medicine is posing a critical need
for noninvasive imaging technology that can provide quantitative tissue and molecular information. The primary
goal of this proposed Bioengineering Partnership with Industry (BPI) project is to develop and validate a new
magnetic resonance-based multimodal imaging technology that can simultaneously acquire a large set of
molecular and tissue property biomarkers from the whole brain in high spatial resolution and imaging speed. To
this end, we have established an Academic-Industrial Partnership and assembled a special project team
consisting of four PIs and seven co-investigators from University of Illinois at Urbana-Champaign, Yale
University, Emory University, Johns Hopkins University, and Siemens Healthineers. The project team has unique
complementary technical, medical and industrial expertise and resources in magnetic resonance spectroscopic
imaging (MRSI) technology development and clinical applications. The project team will collaborate closely to:
a) develop and deliver a next-generation MRSI data acquisition sequence for simultaneous multimodal imaging,
b) develop and build a novel machine learning-assisted data processing pipeline, and c) carry out a multisite
experimental study to evaluate and characterize the performance of the proposed multimodal imaging
technology and assess its clinical potential.
The proposed technology is based on innovative development of 1H-MRSI without water suppression and
machine learning-assisted processing of multimodal data. By utilizing the unsuppressed water spectroscopic
signals, the technology will generate quantitative tissue property maps, including T1, T2, spin density, myelin
water fraction, and magnetic susceptibility at 1×1×1 mm3 resolution, which are important imaging markers for
brain diseases. The technology will also simultaneously measure and quantify multiple endogenous brain
metabolites and neurotransmitters, including N-acetyl aspartate, Myo-inositol, Choline, Creatine, Glutamate,
Glutamine, Lactate, and γ-aminobutyric acid at 2×3×3 mm3 resolution. These molecules provide important
biomarkers for brain neuronal integrity, glial proliferation, cell membrane turnover, astrocytosis, inflammation,
hypoxia, and excitatory/inhibitory synaptic neurotransmission.
When fully developed and validated through this partnership project, the proposed technology will provide
about six-fold reduction in scan time compared with the existing state-of-the-art imaging technology that performs
quantitative tissue property imaging and metabolic imaging independently. The new imaging capability is
expected to greatly enhance our ability to diagnose and characterize brain diseases and assess their treatment
response and efficacy. Although the proposed development and partnership target the Siemens MRI platform
and use a brain tumor application as a testbed, the developed technology will readily be ported to other vendor
platforms and used for other applications, such as neurodegenerative diseases.

Public health relevance
PROJECT NARRATIVE This Bioengineering Partnership with Industry (BPI) project will develop and validate a new technology for simultaneous multimodal brain imaging. The technology will provide an unprecedented capability to acquire a large set of quantitative molecular and tissue property biomarkers of the whole brain using proton magnetic resonance spectroscopic signals on clinical MRI scanners. The technical capability will significantly enhance our ability to diagnose and characterize brain diseases and assess their treatment response and efficacy for personalized and precision medicine.